Renal Afferent Nerve Circuitry and Pathogenesis on Blood Pressure Regulation

PROJECT SUMMARY
Catheter-based renal nerve ablation (CBRNA) decreases blood pressure (BP) and disrupts the chronic
overactivity of sympathetic efferent renal nerves thought to underlie neurogenic hypertension (HTN), diminishing
the risk for developing other cardiometabolic diseases. Studies have demonstrated that a contributor to the
development of neurogenic HTN is sensory afferent renal nerves (ARNs) whose input to central autonomic
regions modulates sympathetic outflow to other organs. Recent work from our lab has identified the close
proximity of ARNs to glomeruli in the renal cortex, which is novel in comparison to the traditional view that ARNs
primarily innervate the renal pelvis. The implication of ARNs in regulating BP and the identification of ARNs in
the renal cortex indicates the need for the role of ARNs in kidney function and autonomic processes to be
investigated. This proposal aims to address this gap in knowledge by 1) elucidating the central
terminations and regional specificity of renal afferents, and 2) identifying how renal afferent input
influences the activity of central autonomic regions that regulate blood pressure using a salt-induced
model of hypertension. Aim 1 will use viral vector-based neurotracing to label ARNs from the renal cortex and
renal pelvis of the kidney to identify their central terminations. I hypothesize that two distinct populations of ARNs
innervate the renal cortex and pelvis respectively, and project to distinct primary central termination sites. Tracing
will be visible throughout the neuroaxis including the renal vasculature, dorsal root ganglia, nodose ganglia,
spinal cord, and brainstem. Aim 2 will be completed using the deoxycorticosterone acetate (DOCA)-salt mouse
model, which induces HTN through sodium and water retention, in targeted recombination of active populations
(TRAP2) mice where the fluorescent reporter protein tdTomato is expressed under the immediate-early gene c-
Fos, a neuronal activation marker, via tamoxifen-inducible Cre. The expression of tdTomato will be quantified as
a direct measure of c-Fos in brain regions known to be involved in BP regulation during early DOCA-salt HTN
development and compared to immunolabeled c-Fos at a later timepoint. I hypothesize that DOCA will increase
the expression of tdTomato and c-Fos in non-denervated mice, and that afferent renal denervation (ARDN) and
an IL-1 receptor antagonist will both attenuate the DOCA-induced neuronal activity. The expected outcomes of
this proposal are to have traced the terminals of ARNs from the kidney to central primary processing centers and
identified changes in neuronal activation in central autonomic centers relevant for ARN processing. These results
will expand the understanding of how ARNs are involved in salt-induced HTN and establish an anatomical
foundation for future investigations into the physiological roles of ARNs in the autonomic control of BP regulation.
Further, these findings may contribute to the potential mechanism by which ARDN attenuates increased BP in
salt-induced HTN allowing the development of interventions that can more accurately target ARNs, both
peripherally and centrally, increasing the therapeutic potential of ARDN as a treatment for hypertension.

Public health relevance
PROJECT NARRATIVE Renal afferent sensory nerves contribute to the development of salt-induced hypertension via input to central autonomic brain regions that modulate sympathetic outflow to other organs. This proposal will expand the understanding of how renal afferents are involved in salt-induced hypertension and establish an anatomical foundation for future investigations into the physiological roles of renal afferents in the autonomic control of blood pressure. With this insight, the field will have a better understanding of afferent renal input from the kidney leading to the development of interventions that can accurately target renal afferents, both peripherally and centrally, increasing the therapeutic potential of afferent renal denervation as a treatment for hypertension.